Celiac and inflammatory bowel diseases: functional post-GWAS approach

ABSTRACT
Celiac disease (CeD) is one of the most prevalent yet understudied gastrointestinal disorders in the U.S., and
there is a critical need to understand genotype-phenotype relationships and underlying mechanisms, to
improve patient care. Likewise inflammatory bowel disease (IBD; comprising ulcerative colitis and Crohn’s
disease), another prevalent autoimmune/inflammatory disorder, presents stubborn challenges including a wide
range of severity and poorly predictable treatment responses. Genomics-based precision medicine for these
diseases will benefit from new approaches that can go beyond genome-wide association study (GWAS) data
to better stratify patients for disease risk, severity, and treatment response. Genotype-dependent allele-specific
DNA methylation (ASM), a focus of our lab (Tycko; HMH-CDI), can be a useful “post-GWAS” tool. Our work
has suggested that ASM differentially methylated regions (ASM DMRs) are footprints of allele-specific
transcription factor (TF) binding, and thus can act as signposts for functional regulatory SNPs (rSNPs) under
GWAS peaks, with direct relevance to CeD and IBD. To apply this approach to a key target cell type in CeD
and CD/IBD, namely the intestinal epithelial cell (IEC), as well as immune cell types, we are collaborating in
multi-PI format with Hamilton and her colleagues at CHOP, who have extensive expertise in biological and
clinical aspects of these diseases. Our project, bolstered by new and extensive preliminary data, combines
genomic + epigenomic mapping with mechanistic studies in cell lines and primary human IEC organoids, to
define which polymorphic TF binding motifs, and which transcriptional pathways and external environmental
signals have roles in CeD and CD/IBD. First, to map ASM DMRs under a greater number of CeD and IBD
GWAS peaks and identify tissue-specific ASM in these regions, we will generate whole-genome bisulfite
sequencing data (WGBS; methyl-seq) from key cell types, with a major focus on IECs. Second, to test
polymorphic TF binding motifs as the underlying mechanism leading to ASM at CeD and IBD risk loci, we will
carry out site-directed mutagenesis in human cell lines using CRISPR-Cas9 and assess the effects on ASM
and allele-specific gene expression. Third, to ask whether external factors in the cellular microenvironment,
converging on cellular TF levels, are reflected in changes in the strength of ASM at CeD and IBD risk loci, we
will manipulate IECs from organoid cultures using a series of disease-relevant external stimuli and identify
changes in ASM strength that correlate with changes in expression of cognate TFs. We expect that our
research will elucidate disease-specific and cell type-specific transcriptional and epigenetic pathways that are
both genotype-dependent and sensitive to acute and chronic effects of the cellular environment, with
implications for future precision medicine approaches that can go beyond GWAS and polygenic risk scores to
incorporate gene-environment interactions – leading to improved disease prevention and treatment.

Public health relevance
NARRATIVE Our project, focused on celiac disease and Crohn’s disease, takes a combined genomic and epigenomic approach to pinpoint and understand the mechanisms of action of genetic variants that regulate critical genes specifically in intestinal epithelial cells or in cells of the immune system, and thereby confer increased risk of these common and difficult to treat gastrointestinal conditions. Our research team includes investigators with expertise in molecular genetics, intestinal epithelial cell biology, bioinformatics and statistical genetics, and clinical aspects of these diseases. Using intestinal organoid cultures from biopsies, with and without exposure to disease relevant external stimuli, whole-genome and targeted DNA methylation sequencing, and CRISPR- Cas9 manipulations in tissue culture, we expect that our research will elucidate cell type-specific biological pathways, and gene-environment interactions, that drive the onset and progression of these diseases, with implications for improved prevention and treatment.